Non pungent capsaicin analogs and ovarian cancer therapy

PROJECT SUMMARY
Capsaicin is the spicy, pungent ingredient of chili peppers. Traditionally, capsaicin is used as a
pain-relieving agent in over-the counter creams and lotions. Published reports demonstrate that
capsaicin displays robust growth-suppressive activity in human ovarian cancers. Apart from its
direct growth-inhibitory activity, capsaicin sensitizes human ovarian cancer cells to the pro-
apoptotic activity of the chemotherapy drug cisplatin. However, the development of capsaicin as
a viable anti-cancer drug is limited by its unfavorable side effect profile. The administration of
capsaicin causes nausea, stomach cramps and gut pain in patients. Such unpleasant side effects
have led patients to abandon using the drug. Structure-Activity Relationship (SAR) studies have
revealed that the addition of unsaturated long chain fatty acyl groups to the C-terminus of
capsaicin yields non-pungent capsaicin analogs (called N-Acylvanillylamides or N-AVAMs) with
robust analgesic activity. The present grant application aims to re-purpose these N-AVAMs and
investigate their anti-cancer in human ovarian cancers. To achieve our objectives, we aim to
screen the anti-cancer activity of a panel of six N-AVAMs in chicken chorioallantoic membrane
(CAM) model of ovarian cancers. We will also examine the ability of N-AVAMs to sensitize human
ovarian cancer tumors towards the growth-inhibitory activity of cisplatin in chicken CAM models
and patient-derived xenograft mice models of ovarian cancer. The central hypothesis of this
application is that non-pungent N-AVAMs will display anti-tumor activity in ovarian cancer
in vivo and will sensitize ovarian cancer cells towards the growth-suppressive activity of
cisplatin. The data obtained from our grant application will foster the development of novel
nutrition-based combination therapies for ovarian cancer patients.

Public health relevance
Public Relevance Statement The studies proposed in this grant propose a structure activity relationship study to foster the development of potent capsaicin analogs as anti-cancer drugs for the treatment and management of human ovarian cancer. These novel drugs will have a better side effect profile than capsaicin. We will also determine the ability of these compounds to sensitize human ovarian cancer tumors to the effects of conventional chemotherapy.